iDAPT: Implementation and Informatics - Developing Adaptable Processes and Technologies for Cancer Control

PROJECT SUMMARY
The Research Program will use three strategies to inform iDAPT’s emerging theme to use technologies that
support rapid cycle and real time deployment and testing of implementation processes and adaptations within
cancer control. First, the Research Program will advance the science of technology-supported implementation
science in cancer control through a series of proposed pilot projects conducted in the Implementation Lab.
Second, it will advance the methods and measurement for implementation science using technology via methods
pilot projects and support of the Implementation Studies Unit. Third, the Research Program will identify and
nurture nascent ideas for new cancer-focused Implementation Science proposals with high potential for
extramural funding, with an emphasis on assisting students, junior faculty, and underrepresented populations.
The Research Program will lead with two pilot studies aligned with our emerging theme of technology-facilitated
implementation science. The first is a highly innovative implementation pilot study that will address a gap in
survivorship care. Using a stepped-wedge design in 10 oncology clinics, we will test an electronic referral
mechanism and computer-tailored communication and intelligent automation to facilitate shared decision making
and survivorship care planning in-between clinical visits. The methods study will advance the field of
implementation science in cancer control by testing the feasibility of using an automated communication pattern
monitoring and feedback system to facilitate implementation programs designed to improve communication
between clinical teams and between clinical teams and patient. This study will create manually annotated
reference standard for natural language processing (NLP), train and validate the NLP system, test the system
among patients undergoing smoking cessation treatment, and then build and test a prototype system to monitor
communication extracted from secure messages over time. Both of these iDAPT vanguard pilot studies are led
by junior faculty. The Research Program will seek additional pilot research through a defined process for
soliciting, reviewing and selecting promising studies using a validated approach for evaluating implementation
research proposals for a total of 8-10 pilot studies. The Research Program depends upon a high degree of
collaboration across the cores to ensure that the selection of pilot studies reflects laboratory member needs
(Administrative Core Evaluation Unit), that laboratory members are engaged and have knowledge and skills to
serve as equal partners in the research process (Implementation laboratory), and that the knowledge gained
from the pilot studies builds the field of implementation science in cancer control aligned with iDAPT’s emerging
theme of technology-facilitated implementation science (Administrative Core Network Unit). The Research
Program is led by Dr. Thomas Houston (MPI) who is Professor and Chief, Health Informatics and Implementation
Science Division at UMMS and is an elected fellow in the American College of Medical Informatics.